Developmental programming of adult stem cells

PROJECT SUMMARY
Early life exposures play a significant role in shaping health and disease susceptibility. Yet, our understanding
of the developmental programming of adult stem cells that maintain tissue homeostasis is limited. Mature adult
intestinal stem cells (ISCs) sustain continuous life-long adaptations to diet and the intestinal microbial milieu to
preserve tissue stability and prevent sequelae leading to diseases such as inflammatory bowel disease (IBD)
or sporadic cancer. ISC’s developmental trajectory is influenced early in life by a maternal environment that
provides extrinsic patterning cues and nutrients to influence cell, tissue, and system maturation. Despite the
fundamental nature of these developmental phases, we do not understand how durable programmable
molecular mechanisms are established or how adverse maternal environmental exposure is maintained in a
stable and homeostatic manner within ISCs. There is a critical need to establish how the environment
contributes to intestinal homeostasis and long-term disease risk. Using genetically engineered mouse and
organoid models, this project aims to distinguish ISC developmental programming and determine both early
intrinsic adaptations and extrinsic environmental interactions that promote establishment of a stable pre-
pathological ISC ground state. Our central hypothesis is that offspring exposure to an obesogenic maternal
environment during pre- and postnatal development establishes a maladaptive pre-pathological ground state
ab initio. In Aim1 we will characterize the extent of altered ISC changes in offspring exposed to maternal pro-
obesity high-fat Western diet (HFD) during pre- and postnatal phases of maternal dependence, and test the
duration that these features exist as offspring age. We will further challenge offspring with the reintroduction of
the HFD and test for pathological states. In Aim2, we will investigate how lipid metabolism drives ISC-
programming by testing for necessity of lipid regulators, Ppar-d and Ppar-a, and for sufficiency with increased
PPAR-d activity. In Aim3, we will explore the role that external signaling from the immune system contributes to
developmental programming and later risk of disease. We will test the necessity of pro-inflammatory cytokine
IL-17 and the influence in tumorigenesis and inflammatory states. In summary, these efforts will enhance our
understanding of how developmental programming in early life leads to health and disease disparities as we
age.

Public health relevance
Project Narrative We propose that offspring’s developmental programming distinctly in intestinal stem cells, established during maternal dependence, is necessary to understand in order to ascertain how the environment contributes to intestinal homeostasis and long-term disease risk. This study advances our emerging understanding of developmental programming in early life that leads to health and disease disparities in later life as we take a genetic and molecular approach using mouse models and organoids to dissect the durable features and reversibility of disease risk in offspring from maternal obesogenic conditions.